Impact of mTor on the aging periodontium and inflammation

Project Abstract Old age is the single greatest risk factor for many diseases including periodontal disease, dementia, diabetes, and heart disease. Aging is associated with failure to maintain homeostasis, and one result is the senescence of the immune system, which results in “inflammaging.” By delaying or reversing the biological aging processes, such as inflammaging, it may be possible to reduce the impact of age-­related diseases, which could have profound benefits for quality of life. The mechanistic Target of Rapamycin (mTOR) has been established as an evolutionarily conserved regulator of longevity through studies showing that reducing mTOR activity extend lifespan and improve healthspan in invertebrates and mice. Rapamycin, a specific inhibitor of mTOR, is a promising candidate for delaying age-­related diseases and may act, at least in part, by reducing inflammaging. An age-­associated inflammatory disease in the oral cavity is periodontal disease. Recent epidemiologic data in the U.S. revealed 64% of adults aged 65 years and older had periodontitis. Here we propose to test the hypothesis that mTOR hyperactivation during aging leads to immune cell senescence, inflammation, and ultimately leads to detrimental changes to the oral microbiome that underlies oral pathology during aging. This will be accomplished first by assessing mTOR signaling in the periodontium during aging through quantification of phosphorylation of mTOR pathway components and inflammatory markers. To determine if the periodontium of normally aged mice is comparable to an induced inflammatory state, comparison of aged rodents to a ligature-­induced periodontitis model will be completed. In preliminary studies, we have shown that age-­associated periodontal bone loss in mice was improved after rapamycin treatment. Thus, the ability of rapamycin to attenuate age-­associated oral pathology and effects on innate immune response in ligature-­ induced periodontitis will be explored. Furthermore, the consequence of aging and mTOR inhibition on the oral microbiome will be investigated. The proposed F30 project was developed to help provide a foundation for an aspiring dentist-­scientist and contribute to understanding the mechanistic and molecular basis for age-­associated changes in the periodontium. Investigating mTOR signaling in the periodontium, and understanding the role of rapamycin in delaying inflammaging in the oral cavity will have a significant impact on the fields of geroscience and dentistry, and could potentially yield major improvements in public health. With strong institutional support from the University of Washington and excellent mentorship, we are confident that this F30 award will aid in the basic sciences and clinical training required to be a successful dentist-­scientist.

Public health relevance
Project Narrative Aging is associated with chronic inflammation called inflammaging, which contributes to periodontal disease that afflicts more than 6 out of 10 people over the age of 65.1- 6,15 The goal of this proposal is to define the molecular mechanisms by which aging and inflammaging contribute to periodontal disease and decline in oral health. This will be accomplished by testing the hypothesis that aberrant signaling through the mTOR growth promoting pathway drives inflammation in the oral cavity and evaluating the impact of rapamycin, an FDA approved inhibitor of mTOR, on progression of age- associated periodontal disease in mice.